Circadian Regulation of Cardiomyocyte Size and Function

PROJECT SUMMARY
The overall objectives of this study are to 1) establish hiPSC-CMs as robust models for mechanistic studies of
how intrinsic circadian regulation impacts cardiomyocyte size and function and 2) determine whether mutations
that impact cellular size and function also disrupt cardiomyocyte clock rhythms.
In the heart, disruptions in circadian rhythms stemming from irregular sleep, jet lag, or shift work can lead to
heart attacks, arrhythmias, and cardiac dysfunction. Prior research shows that disrupting the clock via Bmal1
knockout in mouse cardiomyocytes induces age-dependent hypertrophic cardiomyopathy (HCM) with adverse
myocardium remodeling, marked by enlarged cardiomyocytes. These data underscore the importance of
studying circadian regulation on cardiomyocyte size and function.
Most of our current understanding of how circadian clock disruption leads to cardiac abnormalities is derived
from animal studies influenced by the suprachiasmatic nucleus (SCN) pacemaker. Consequently, our
understanding is limited to how intrinsic cardiomyocyte circadian clocks function independently of the SCN. To
address this gap, developing an in vitro cell model will be crucial. Such a model would enable circadian regulation
of cardiomyocyte size and function to be studied separately from SCN influence, providing valuable insights into
how the intrinsic clock autonomously governs cellular processes. Understanding these mechanisms is essential
for unraveling the intricate relationship between circadian rhythms and cardiac health at the cellular level.
Human-induced pluripotent stem cell-derived cardiomyocytes (hiPSC-CMs) have emerged as invaluable disease
and drug screening models. These cells also offer a unique opportunity to investigate the circadian regulation of
cardiomyocyte size and function in a controlled in vitro environment independent of SCN influence. Due to their
inherent immaturity, interventions targeting clock function in these cells at an early stage can elucidate the
mechanisms by which circadian rhythms influence changes in cell size and function. Moreover, hiPSC-CMs
serve as established models for inherited genetic mutations, offering a distinctive chance to explore how inherited
genetic disorders, such as hypertrophic cardiomyopathy, which results in enlarged cardiomyocytes and
hypercontractile function, disturb circadian rhythms.
The results of these aims will 1) establish hiPSC-CM as a model to obtain critical new information on how the
intrinsic cardiomyocyte clock impacts cell size and function and 2) inform us of the potential of targeting the clock
to treat genetic cardiomyopathy. The training provided in this K01 will enable the candidate to become an expert
in circadian regulation of cardiomyocyte size and function and establish an independent research career.

Public health relevance
Project Narrative The results of this study will establish human induced pluripotent stem cell–derived cardiomyocytes (hiPSC-CM) as a model to obtain critical new information on how the intrinsic cardiomyocyte clock impacts cell size and function. These data will also inform our knowledge of whether inherited genetic mutations that lead to hypertrophic cardiomyopathy resulting in increased cardiomyocyte size and contractile dysfunction can disrupt circadian rhythms. The impact of this study is that it will provide a mechanistic understanding of the interplay between the circadian clock and its regulation of cardiomyocyte size and function while also answering the question of whether the circadian clock in the heart is altered during hypertrophic states.